Buffalo Oral-Research and Specialty Training Program (BORST)

PROJECT SUMMARY / ABSTRACT
This is a renewal application for a K12 grant to continue support for the Buffalo Oral-Research and Specialty
Training (BORST) Program, an integrated research training program based in the School of Dental Medicine at
the University at Buffalo (UB). The overarching objective of BORST is to foster the development of dental
specialist-scientist scholars focused on oral, dental and craniofacial research. To accomplish this goal, BORST
offers mentored, interdisciplinary research training opportunities in oral health, craniofacial biology and
bioengineering. BORST provides a strong curriculum and thematic research experiences in an integrative
framework that emphasizes mentoring, scientific advancement, academic career development, grantsmanship,
and productivity. This K12 application requests support for dentists to engage in clinical specialty training and
PhD research training for dentist-scientists in basic, translational or bioengineering sciences important to
dental, oral or craniofacial health. BORST is an integral part of the School of Dental Medicine that engages
faculty and trainees/scholars in other disciplines and departments in the School of Medicine and
Bioengineering at UB. Mentoring and career development activities are thematically grouped into 5 strategic
areas of research focus: (i) immunology and innate defenses, (ii) relationship of oral pathogens to systemic
disease, (iii) saliva and salivary glands, (iv) microbial pathogenesis of oral organisms, and (v) bone and
connective tissues/tissue engineering. BORST benefits from outstanding and time-tested administrative
support systems and institutional commitment that will provide continued support to the Department of Oral
Biology. The BORST Program will support two postdoctoral scholars each year of the award who will engage
in this combined career development program. The goal for the BORST Program is to provide early career
development for talented dentists who wish to pursue research and academic careers as dental specialists
with a PhD. An integrated, multi-year evaluation plan will be used to measure the extent to which BORST goals
and objectives are met. The resulting scholars will be well prepared to engage in meaningful basic and/or
translational oral health research.

Public health relevance
PROJECT NARRATIVE There remains in the United States a critical need for well-trained investigators in dental, oral and craniofacial research. This institutional career development application supports the Buffalo Oral-Research and Specialty Training Program (BORST) Program, an integrated program based in the School of Dental Medicine at the University at Buffalo to help train the next generation of dental specialist-scientists engaged in dental, oral and craniofacial research. Career development opportunities will include clinical dental specialty training disciplines of periodontics, orthodontics and oral pathology combined with integrated graduate research areas of immunology/innate defenses, relationship of oral pathogens to systemic disease, saliva and salivary glands, microbiome, and bone and connective tissues/tissue engineering.